Statistical methods for analyzing objectively measured physical activity.

Project Summary/Abstract
This project aims to develop new analytic tools for understanding accumulation patterns of physical activity (PA),
sedentary behavior (SB) and sleep in the 24-hour activity cycle and to ﬂexibly model these patterns and health
outcomes, such as cardiovascular diseases, and apply these methods in PA epidiological studies that collected
objective measurements by accelerometry or wearable devices. In physical activity epidemiology, each inten-
sity/behavior category has been investigated separately in association with health outcomes. However, this
approach fails to account for the inter-relatedness and interactions among of these activities. In fact, the 2018
Physical Activity Guidelines Advisory Committee Scientiﬁc Report identiﬁed 24-hour cycle and dose-response
PA/SB accumulation patterns among the most important and critical issues that clearly need future research for
informing the next set of physical activity guidelines.
Motivated by this critical need, we propose novel statistical methods to utilize the rich information collected by
accelerometry in a few directions. First, we develop robust functional data analysis methods for ﬂexibly modeling
associations between accelerometry-measured PA trajectories and health outcomes. Second, we develop ﬂexible
functional data analysis methods for characterizing dose-response relationships between PA/SB accumulation
patterns and health outcomes, using an interpretable functional principal component analysis approach. Third,
we plan to develop nonparametric compositional data analysis (NCDA) methods for extracting patterns of the 24-
hour activity cycle, extend the approach to longitudinal studies and to ﬂexibly investigate associations between
24-hour activity compositional patterns and health.
The proposed analytic tools are directly motivated by and will be immediately applied to ancillary studies of
the Women's Health Initiative (WHI) that we are involved in, the Objective Physical Activity and Cardiovascular
Health (OPACH) Study, WHI Strong and Healthy Trial (WHISH), the Sedentary Time and Aging (STAR) Program,
the Women's Health Accelerometry Collaboration (WHAC), as well as the publicly available National Health and
Nutrition Examination Survey (NHANES) and UK Biobank data.

Public health relevance
Project Narrative This project aims to develop new analytic tools for understanding how accumulation patterns of physical activ- ity, sedentary behavior and sleep in the 24-hour activity cycle are associated with health outcomes, such as cardiovascular diseases.